Understanding the Mechanism of HIV Associated with Diabetic Complications in Low- and Middle-Income Country

PROJECT SUMMARY
Our proposed project is designed to investigate the immunopathological basis of NK cell-mediated pancreatic
insufficiency which may lead to the future occurrence of diabetes mellitus (DM) among people living with HIV
(PLWH). Furthermore, we plan to explore HIV/antiretroviral therapy-induced endoplasmic reticulum (ER) stress
as a contributory pathophysiological phenomenon which would render pancreatic tissue more susceptible to
immune-mediated destruction in this population, with attempts to mitigate this through low-cost, ER stress-
inhibiting medication. Our comprehensive analysis of the altered immunophenotype among PLWH has revealed
several subsets of activated, pro-inflammatory NK cells dominating the circulation. We have also successfully
demonstrated direct effects of these altered NK cells among PLWH in contributing to the ongoing risk of other
non-communicable diseases (NCDs) like atherosclerotic cardiovascular disease at a very young age. Based on
our previous research findings and existing literature, we have gathered sufficient evidence to back our proposed
studies. Our epidemiological findings have collectively predicted an increased risk of DM in an expanding HIV
population dominated by young adults in Sri Lanka, a lower-middle income country (LMIC) in South Asia, which
relies heavily on an active workforce for sustenance of its fragile economy. We strongly believe that our proposed
work and its main outcomes may broaden our understanding of the NK cell-mediated immunopathogenesis of
such NCDs and socioeconomically acceptable therapeutic/preventive strategies which could be implemented in
these critical populations in the future. We also believe that our exploratory study would create a significant
impact and ignite further research in this field of study. By conducting this project in an LMIC setting like Sri
Lanka, we hope to foster a network of research collaborations between two diverse settings, with plans to
strengthen the research infrastructure related to HIV and its comorbidities in Sri Lanka. Through our proposed
scientific techniques such as high-dimensional flow cytometry, novel immunohistochemical techniques,
transcriptomics and epigenomics, we hope to carryout exchange of knowledge and expertise and between our
study settings and help build necessary infrastructure in Sri Lanka in an effort to lay the groundwork for future
collaborations on HIV related research in this setting.

Public health relevance
Project Narrative While unrestricted access to antiretroviral therapy (ART) has allowed people living with HIV (PLWH) in low- and middle-income countries (LMICs) to approach near-normal life expectancies, the long-term health consequences and socioeconomic burdens stemming from increased comorbidities such as diabetes mellitus (DM) in these individuals have significant implications on both an individual and national scale. Consequently, unraveling the pathogenicity linked to these comorbidities and investigating viable therapeutic and/or prophylactic strategies becomes of paramount importance. Our study will set the stage for broader-scale studies aimed at mitigating DM and other risks of non-communicable diseases in these vulnerable populations within resource-deprived settings.